Innovative Computational Tools and Best Practice Recommendations for Analyzing HIV-related Count Outcomes

Critical health- and treatment-related outcomes such as adherence to antiretroviral therapy (number of doses
taken out of those prescribed), substance-related problems (e.g., number of problems endorsed), and frailty
(e.g., number of Fried Frailty Phenotype criteria experienced) frequently take the form of fractions or
proportions. However, fractional and proportional outcomes generally have not been appropriately analyzed in
the behavioral HIV field and health outcomes research more broadly, which may lead to invalid conclusions.
For example, outcomes such as the proportion of prescribed doses taken are highly skewed with both floor and
ceiling effects (i.e., at 0 and 1), which violate the assumptions of commonly used statistical models, such as
linear regression. We propose the marginalized zero- and N-inflated binomial (MZNIB) model to assess the
overall effects of covariates (e.g., treatment effects) on proportional outcomes. The MZNIB model produces
regression estimates that share the familiar interpretation of logistic regression by focusing on the mean
probability of the target outcome (e.g., medication adherence) across the entire population. The MZNIB
approach provides a more straightforward estimation of an overall effect than traditional zero-inflated models or
other alternatives, which produce multiple sets of estimates on fractional outcomes that distinguish, for
example, between those who (1) potentially engage in the behavior (e.g., take HIV medication at least
occasionally) and (2) never engage in the behavior. In clinical research, it is critical to quantify the overall effect
as a benchmark to compare effects, identify reasons for heterogeneity in effects, and improve on effects. Lack
of appropriate methods, especially for HIV research, remains a barrier to innovative treatment development
and evaluation. To address this gap, this R21 study has three aims: (1) provide best practice recommendations
via simulation study regarding when and how the MZNIB model would be preferred over existing approaches
for evaluating medication adherence and other proportional outcomes with floor and ceiling effects, (2) produce
tutorials for implementing the MZNIB approach to estimate effects of treatment and other predictors using real
data from three HIV intervention/prevention trials and a large-scale HIV cohort study (Ns = {70, 73, 224,
9336}), and (3) develop and disseminate the first-ever open-source computational tool for the MZNIB model.
This R21 study leverages an established research group with combined expertise in HIV, substance use, and
frailty. Findings from this study will empower behavioral HIV research communities by introducing novel
statistical models and explaining their assumptions, advantages, and disadvantages in one coherent analytic
framework. Simulation studies, accessible tutorials, and substantive application papers that address fractional
count outcomes will improve statistical inference and scientific rigor. In addition, we will develop computing
tools for greater dissemination and implementation of the methods studied. The R21 will support extensions of
the MZNIB model to clustered and longitudinal data, and additional computational tools in a future R01 study.

Public health relevance
This work will provide public health and clinical researchers with accessible computational tools and easy-to- understand guidance for evaluating treatment-related outcomes in HIV and health-related research that take the form of fractions or percentages, such as medication adherence. The new marginalized zero- and N- inflated binomial (MZNIB) statistical model and companion computational tools are expected to have greater accuracy and sensitivity than existing statistical approaches for identifying effective treatments, which can better inform evidence-based practice and guide treatment recommendations and individual healthcare decisions.